Breaking down barriers: defining the role of EphA2 in building epidermal tight junctions in atopic dermatitis

Perez White, Bethany 5K01AR072773-03 Administrative Supplement Request PROJECT SUMMARY Tight junctions are a vital component of the epidermal barrier and are required for skin function. While we know these structures are disrupted in skin diseases such as atopic dermatitis (AD), we do not fully understand the normal signaling contributing to their function. This knowledge gap makes finding therapies to restore tight junction activity difficult. Therefore, defining the signaling pathways responsible for establishing tight junctions would serve not only to advance our basic understanding of skin biology, but also may provide leads for drug targeting and disease intervention. Our preliminary evidence indicates that EphA2 receptor tyrosine kinase (RTK) contributes to the formation and function of tight junctions in 2D cultures. Genetic manipulation of these cultures to remove EphA2 results in a loss of the localization of tight junction proteins from the stratum granulosum in which they reside. In addition, we have found a loss of tight junction function by measuring electrical resistance and the permeability of large molecules in 2D keratinocyte cultures. Based on these changes in epidermal integrity after loss of EphA2, we hypothesize that EphA2 is a positive regulator of tight junctions in the epidermis and can be targeted to improve tight junction barrier function. We specifically will determine how EphA2 is regulating tight junctions and if EphA2 could be targeted pharmacologically to enhance skin barrier function. Our initial studies implicate the structural protein afadin, downstream of EphA2 signaling, as a positive regulator of the formation and function of tight junctions in epidermal keratinocytes. Our studies have found that EphA2 loss leads to the mislocalization of afadin from cell borders to the cell's interior regions, and a loss in afadin and tight junction proteins. Therefore, we will first test the effect of EphA2 and afadin loss on the assembly and functionality of tight junctions in 3D reconstituted human epidermis (3D RHE). We will next test the mechanism by which EphA2 alters afadin expression, leading to tight junction defects. We have also uncovered novel EphA2/EGFR RTK crosstalk that is integral to TJ morphogenesis. Finally, we will use 3D RHE and animal models of AD to determine if EphA2 ligand activation with ephrin-A1 can enhance tight junction barrier function and either prevent or reverse the manifestations of this disease. AD is a prevalent skin disease primarily affecting infants and young children characterized by an epidermal barrier defect in association with skin inflammation. This chronic condition severely decreases the quality of life of patients and their families, and causes a significant lifelong economic burden. By understanding the biology of tight junctions, a critical structural component of the skin that is dysfunctional in AD, we can seek new therapies to alleviate this disease. We have proposed that the EphA2/ephrin-A1 signaling axis can be harnessed to normalize tight junction defects in AD.

Public health relevance
PI: Bethany E. Perez White Re: Project Narrative Tight junctions are vital to skin and are disrupted in atopic dermatitis. However, we do not understand the normal mechanisms contributing to tight junction function, making therapies to enhance their activity elusive. EphA2 is a protein involved in tight junction signaling, as its loss decreases tight junction function. We suggest that ephrin- A1, an activator of EphA2, can enhance tight junctions and repair the barrier dysfunction of atopic dermatitis.